2022 Food Allergy Gordon Research Conference and Seminar

Abstract Food allergy affects up to 8% of the US population, but research in food allergy has lagged behind that of other atopic diseases. There has been a marked uptick in research in food allergy in the past 10 years, contributing to FDA approval of the first therapy for peanut allergy in 2020. There is more interest in food allergy from a variety of disciplines, and there is a need to capitalize on this increased interest to accelerate growth in the field. We are proposing the 2022 Gordon Research Conference in Food Allergy as a means to increase the breadth, diversity, and inclusion of our food allergy research community. We think that increasing diversity of experience and perspective (scientific and personal) will promote the excellence of the field and ensure the continued and expanded growth of food allergy research. Our proposed scientific program will focus on emerging science in food allergy obtained from mouse models, human immunology, and clinical trials. This conference will highlight advances in our understanding of immune mechanisms of allergy and tolerance to foods. Novel areas of concentration include key systems that interact with and shape immunity, including microbiome, the nervous system, and the neuroendocrine system. We will also highlight science supporting emerging treatment approaches for food allergy. Through bringing together the best science/scientists in and related to the field of food allergy, and the promotion of young scientists and scientists from groups underrepresented in the field, our objective is to spark collaborations and new paradigms that will accelerate the growth of the food allergy research field.

Public health relevance
Narrative Food allergy affects 8% of the US population and is a significant economic and quality of life burden, also disproportionately affecting Black and Hispanic populations. To accelerate growth of the food allergy research field in order to develop prevention and treatment approaches, we need to bring a diverse group of scientists with interest in and around food allergy together to spark collaboration and novel research ideas. This is the objective of the 2022 Food Allergy Gordon Research Conference.